IGF::OT::IGF - SUPPORT SERVICES FOR EPIDEMIOLOGY - TASK ORDER 2 - RESEARCH DEVELOPMENT

The purpose of this Task is to conduct research related activities for NIEHS Epidemiology Branch Investigators that do not fall under a specific Task Order. The Contractor will also support field data collection efforts of limited duration or size that do not warrant a distinct field Task Order.